Aging effects on the neural coding of proactive and reactive cognitive control: Administrative Supplement

Project Summary
This proposal explores the neural and psychological mechanisms that underlie the well-established declines in
cognitive control function experienced by otherwise healthy older adults. A clear consensus in the cognitive
neuroscience of aging is that age-related cognitive control declines reflect neurobiological changes that occur
in the functioning of the mid-brain dopamine system, interacting with targets located in the lateral prefrontal
cortex (lPFC) and anterior cingulate cortex (ACC). The current proposal adopts an innovative experimental
approach to this issue, by leveraging the methodology of representational similarity analysis (RSA), to
examine the neural coding of cognitive control and how it changes with advancing age. Specifically, we utilize
RSA to test the Dual Mechanisms of Control (DMC) theoretical framework, which postulates that older adults
will exhibit clear impairments in the engagement of proactive control, but relative preservation of reactive
control. The project directly tests this hypothesis, employing novel theoretically-optimized variants of the work-
horse color-word Stroop paradigm, combined with RSA methods, to examine the neural mechanisms
associated with proactive and reactive control, using a multi-modal neuroimaging approach involving matched
fMRI and EEG studies. This multi-modal approach enables a systematic and comprehensive test of the DMC
framework, to test whether proactive and reactive control have distinct temporal dynamic signatures, and involve
anatomically dissociable neural mechanisms within the lPFC and ACC. We further propose to enrich our
understanding of the mechanisms of age-related change in cognitive control function, by capitalizing on recent
advances in the ability to assess risk of preclinical Alzheimer’s Disease (AD) and AD-related
neurodegeneration through the use of blood plasma-based biomarkers. Through new collaborations with Dr.
Brian Gordon, Dr. Ryan Bogdan, and Dr. Suzanne Schindler, we will utilize state-of-the-art methods, including
single-molecule array (Simoa) and mass spectrometry, to comprehensively assess key blood-based biomarkers
related to amyloid (APOE, beta-amyloid), tau (ptau181), and neurodegeneration (NfL, GFAP), as well as
anatomical MRI biomarkers (e.g., cortical thickness). We propose an Administrative Supplement to provide
additional support for us to acquire, process and rigorously analyze AD-related biomarker data. This Supplement
will dramatically enhance the scope, impact, and

Public health relevance
Project Narrative One of the challenges of healthy aging is the decline that many older adults experience in key aspects of higher cognitive functioning, particularly those that involve cognitive control: the use of behavioral goals to successfully regulate thoughts, emotions and actions. This project will provide critical and detailed information regarding the brain basis of declining cognitive control among older adults, with the goal of identifying key neural markers that can be used as targets for future diagnostic and intervention efforts.